Training and Dissemination

NCAN Training & Dissemination focuses on enabling the widespread use of new neurotechnologies for important
purposes and improving the training of scientists, engineers, and clinicians to develop and use them. While many
exciting neurotechnologies have been developed and validated in the lab, few have been translated to clinical
practice, largely due to the lack of an appropriate environment, or ecosystem. An effective neurotechnology
ecosystem requires: people who understand the principles of the technology and are skilled in its use; access to
robust, compatible, and supported hardware and software; and mechanisms that support effective interactions
among the scientists, engineers, and clinicians involved. Over the past 20 years, Wadsworth staff created such
an ecosystem for BCI2000, a general-purpose software platform that facilitates neurotechnology research and
development. NCAN Training and Dissemination activities are building on this experience to create a much more
comprehensive ecosystem for a wide range of adaptive neurotechnologies.
To train scientists, engineers, and clinicians in the theory and practice of adaptive neurotechnologies in the next
grant period, NCAN will: (a) update and expand its comprehensive curriculum by incorporating the new theoretical
understanding about CNS plasticity conceived in the NCAN's ﬁrst grant period and practical aspects of the design
and use of the neurotechnologies developed through each TR&D's collaborative projects; (b) design and conduct
courses and workshops based on this updated curriculum, including the comprehensive Short Course in Adaptive
Neurotechnologies, ECoG and BCI2000 workshops, and new ﬁve-day Focus Courses in EEG-based BCIs and
spinal reﬂex conditioning methodologies; (c) expand the undergraduate and graduate intramural training programs;
and (d) obtain continual feedback on these training activities and use it to improve them.
To disseminate knowledge of and access to adaptive neurotechnologies to scientists, engineers and clinicians,
NCAN will: (a) develop topic-speciﬁc Mini-Courses that will allow other institutions to create or supplement their
own curricula with material on adaptive neurotechnologies; (b) update and expand its dissemination channels,
including the NCAN and BCI2000 websites and newsletters, NCAN exhibits at relevant meetings, and NCAN's
online BCI article database; and (c) evaluate the efﬁcacy of these dissemination activities through periodic
quantitative assessments (e.g., website use, research and clinical studies published) and modify them in response
to this feedback.
In summary, NCAN will continue and enhance training and dissemination activities that create and maintain an
ecosystem of people, knowledge, and technology that enables and promotes the widespread use of adaptive
technologies by scientists, engineers, and clinicians to address important scientiﬁc and clinical problems.